Shape-Adaptive Cochlear Implant Electrode Arrays

Project Summary/Abstract
During this Phase I SBIR effort, we will assess the viability of shape-adaptive cochlear implant (CI) electrode
arrays as a new solution for achieving atraumatic cochlear implantation and optimal electrode positioning at the
same time. Lateral wall electrodes have historically been the preferred CI electrode option due to the higher
likelihood of achieving atraumatic insertion and preserving residual hearing. However, placing electrodes closer
to the modiolus of the cochlea can offer potential performance benefits, such as more focal stimulation and
reduced current spread, due to shorter distance from the electrode to the spiral ganglion neuron target.
Unfortunately, conventional perimodiolar electrodes suffer from higher rates of trauma and electrode
displacement (translocation), negatively affecting the preservation of residual hearing.
Here, we are addressing this long-standing challenge by utilizing shape-memory polymers (SMP) as a dynamic
element that induces programmed self-curling of the CI electrode arrays in the inner ear. This approach facilitates
gentle and gradual repositioning of the implanted arrays from the lateral wall to the modiolar wall without trauma.
By combining the advantages of both lateral wall electrodes (i.e., atraumatic insertion) and perimodiolar
electrodes (i.e., focal placement), the proposed technology enables reliable cochlear implantation and optimal
electrode placement at the same time, which is difficult to achieve with the current clinical CIs.
Our effort encompasses fabrication of SMP-inlaid, self-curling CI arrays, assessment of their implantation profiles
in a model cochlea as well as human temporal bones, and evaluation of insertion trauma by a histological
evaluation. We will rigorously validate our approach through mechanical and surgical analyses including dynamic
mechanical analysis and quantitative assessments of the insertion profiles based on macroscopic and
microscopic imaging.

Public health relevance
Project Narrative Cochlear implants (CIs) have been one of the most prevailing neural prostheses, yet a significant number of CI recipients still experience only poor to moderate speech understanding. Current CIs have trouble achieving simultaneous atraumatic insertion and effective placement of intracochlear electrodes, and we are tackling these challenges by using a novel approach using shape-memory polymers (SMPs) as a mechanically-adaptive element for CI electrode arrays. This project will validate that the SMP-inlaid CI electrode arrays will lead to more reliable cochlear implantation alongside favorable electrode placement.